Reproductive and Developmental Sciences Training Program - T32

Project Summary/Abstract
Because research into both animal and human reproductive biology has such widespread implications for human health,
we established the Reproductive and Developmental Sciences Training Program (RDSTP) at Michigan State University.
Housed within a large group of accomplished investigators and supported by substantial institutional commitments, the
RDSTP trains young scientists to pursue research in High Priority Program Topic Areas identified by the NICHD/Fertility
and Infertility (FI) Branch and the Gynecologic Health and Disease Branch. To provide training related to these NICHD
target areas, the RDSTP trainees select from among four Areas of Specialization: Gonad and Gamete biology, Early
Development, Reproductive Tract Biology and Gynecological Pathologies, and Environmental Factors impacting
Reproduction. Each area contains multiple faculty trainers offering outstanding research opportunities and training
environments in each of their specific areas of expertise. The Reproductive and Developmental Sciences program at
Michigan State University has expanded extensively in the past five years with substantial institutional commitment, and
is continuing to expand which provides a dynamic and rich environment for training young scientists. The RDSTP will
pursue the objectives of providing competence in emerging, cutting-edge, NICHD-recognized areas of high research
interest, and providing essential skills for long-term career and professional development, with qualifications to
participate in the broader roles of scientists in our community. The latter will include developing laboratory skills,
rigorous, responsible and reproducible approaches to research, verbal and written communication skills, management and
mentoring skills, diverse other professional skills, teaching skills, and other expertise that will be essential for future
success in both academics as well as alternate career opportunities. A research mentoring optimization program aimed at
both trainee and trainers, education about career path diversity, and coordination with numerous programs at MSU that
enhance diversity collectively elevate the program to the highest of standards for training and professional development.
The training program is designed to ensure that trainees are fully equipped to meet the challenges required to succeed in
any professional environment be it academics or other diverse career paths in which their scientific training can be fully
utilized.

Public health relevance
Project Narrative Research into both animal and human reproductive biology has widespread implications for human health. The Reproductive and Developmental Sciences Training Program (RDSTP) at Michigan State University seeks to continue training young scientists to have the ability to succeed and establish careers critical to research priorities established for the reproductive sciences as well as alternate careers that will enhance the field.